Estrogen Receptor Signaling in the Expression of Respiratory Motor Plasticity

PROJECT SUMMARY/ABSTRACT
The respiratory control system displays a remarkable capacity for neuroplasticity, imparting flexibility of breathing
in response to changing physiological or environmental conditions across the lifespan. Gonadal hormones
(estrogens, progestins, androgens) exert powerful modulatory effects and directly influence the development of
neuroplasticity in other neural control areas. Yet, the role of gonadal hormone signaling in the development
respiratory neuroplasticity has not been clearly defined. The overarching hypothesis guiding this proposal is that
gonadal hormone signaling within the spinal cord is necessary to enable expression of respiratory
neuroplasticity through regulation of spinal microglia. Five important preliminary findings support this
hypothesis. First, while estrogens and progestins are typically associated as the principal gonadal hormones in
females, whereas androgens are considered the primary gonadal hormone in males, it is in fact estradiol in both
sexes that is required to permit respiratory neuroplasticity. Second, testosterone is aromatized to estradiol
directly within the spinal cord to elicit plasticity in males. Third, the estrogen receptor isoforms (ERα, ERβ and
GPER) essential for enabling respiratory plasticity are unique in females and males. Fourth, estradiol
supplementation or the pharmacological activation of spinal estrogen receptors is sufficient to rescue plasticity
following removal of the gonads in both sexes. Fifth, treating the spinal cord with a localized anti-inflammatory,
or reducing the population of CNS microglia (using a CSF1R inhibitor), is sufficient to restore respiratory
neuroplasticity in rats of both sexes following removal of the gonads, indicating a role for spinal microglia in the
estrogen-induced recovery of plasticity. Using rigorous neurophysiologic measures of respiratory neuroplasticity
in combination with estrogen receptor pharmacology, targeted gene manipulation by siRNA knockdown, flow
cytometry, mass spectroscopy, and protein biochemistry, we will dissect the role of spinal estrogen receptor
signaling for expression of respiratory neuroplasticity. Three specific hypotheses will be tested: 1) Spinal ER
signaling is necessary for induction of respiratory neuroplasticity in female and male rats; 2) Spinal estrogen
signaling is sufficient to restore respiratory plasticity when sex steroid levels are systemically reduced; and 3)
Estrogen permits respiratory plasticity through modulation of spinal cord microglia. These studies address a
critical gap in our basic biological understanding of respiratory neural function; how sex hormone signaling
enables development of respiratory neuroplasticity. In addition, our results will directly inform ongoing
translational studies targeting mechanisms of respiratory neuroplasticity for therapeutic benefit.

Public health relevance
PROJECT NARRATIVE Neuroplasticity is an essential characteristic of the respiratory neural control system; imparting flexibility in respiratory responses to internal physiological changes or external environmental challenges across the lifespan. Yet, despite considerable research defining the cellular and molecular mechanisms of respiratory neuroplasticity over the past three decades, we still know very little about sex differences or the specific role of sex hormones in the development of respiratory neuroplasticity. To address this gap in basic biological knowledge and support on-going translational studies devising novel ways to manipulate mechanisms of neuroplasticity for therapeutic benefit, our project investigates the mechanisms by which sex hormones, and specifically 17β-estradiol (the most abundant and neuroactive sex hormone in females), enable the development of respiratory motor plasticity in both females and males.